Gut microbiome, aging and cardiometabolic diseases in American Indians

Project Summary
Aging and age-related cardiometabolic diseases (CMDs) such as obesity, type 2 diabetes, hypertension,
cardiovascular disease, and chronic kidney disease, along with their risk factors (e.g., insulin resistance,
inflammation, dyslipidemia, etc.), result from the complex interplay between genetic, lifestyle, and
environmental factors. American Indians (AIs) suffer disproportionately from these chronic cardiometabolic
conditions. Gut microbiota (bacteria, viruses, fungi, multicellular parasites, and archaea in our intestine) has
emerged as a novel, metabolically active “organ” that regulates many key biological processes and
physiological functions. Gut dysbiosis (imbalance in gut microbial community, e.g., loss of microbial diversity or
beneficial microbes, expansion of pathogenic microbes) has been associated with chronic metabolic disorders.
However, several fundamental knowledge gaps exist, e.g., what are the key microbial signatures associated
with aging and CMDs? What host factors shape the gut flora and how? What are the specific microbes or
microbial species in human gut, and how does their composition and function differ across different
populations/ethnic groups? Is the variation in human gut microbiota influenced by host genome, and if so, to
what extent? Despite these unknowns, it is well accepted that the gut microbiome varies significantly among
individuals and its composition heavily depends on an individual’s age, gender, geography, dietary preference,
lifestyle, health status, etc. Since AIs suffer from high rates of obesity and diabetes, live on reservations or
other tribal lands, eat traditional food and medicine, and practice other unique lifestyles, it is possible that they
harbor different sets of disease- and health-associated gut microbiomes compared to other populations/ethnic
groups. The objectives of this study are to address these fundamental questions by generating the first
complete map of the human gut microbiome and identifying key microbial features associated with aging and
CMDs in American Indians. To achieve this, we will leverage the parent SHS Phase VII (funded by NHLBI as a
contract, 2019-2026) that will re-exam all living participants (N~=3,000) in 2020-2024 to collect stool samples
from 1,500 well-phenotyped AI participants. We will conduct whole-genome shotgun metagenomic sequencing
and perform innovative statistical analyses to: (1) identify key age-related gut microbiome features associated
with biological aging (assessed by leukocyte telomere length) and CMDs (Aim 1); (2) identify host factors that
shape the human gut microbiota in AIs (Aim 2); (3) explore the mechanistic links between gut dysbiosis, aging,
and CMDs (Aim 3). Our long-term goal is to understand the mechanisms through which gut microbes interact
with host factors in leading to accelerated aging and CMDs, with an ultimate goal to develop novel, precision
therapeutic interventions (e.g., diet, drugs, live organisms, fecal microbiota transplantation) to promote healthy
aging and improve cardiometabolic health.

Public health relevance
Project Narrative Aging and age-related cardiometabolic diseases (CMDs) such as obesity, diabetes, cardiovascular disease are the major cause of morbidity and mortality and disproportionately affect American Indians. The human gut flora has emerged as a potential therapeutic target for anti-aging and preventing or treating CMDs. This study is to identify key gut flora features associated with aging and CMDs as well as modifiable factors (e.g., diet, drug, live organisms) that can modulate the effects of gut flora on aging and cardiometabolic risk. Findings of this study may lead to novel, microbiota-based precision strategies for healthy aging and cardiometabolic health, in addition to providing new insights into disease pathogenesis.